Genetic substrates of cue-reactivity and cocaine motivation

PROJECT SUMMARY
Understanding the genetic factors that contribute to the transition from recreational to problematic drug use is
vital for uncovering biological mechanisms that can aid in preventing and treating substance use disorders
(SUDs). Genome wide association studies (GWAS) have been successful in identifying genetic variants, but
validating these genes is diĜcult given that human research is limited to non-invasive approaches. Other
approaches include integrating GWAS results with large-scale ‘omics’ datasets, and conducting functional
studies in animal models. One such model is the intermittent-access cocaine self-administration procedure
(IntA), which triggers increased cocaine motivation (i.e., incentive sensitization) in rats after only limited
amounts of drug exposure. This models the transition into early stages of SUD and, when compared to other
procedures, can be used to dissociate total drug intake from incentive sensitization. To uncover the genetic
factors behind incentive sensitization during IntA, our team has conducted a GWAS in a limited sample of
heterogeneous stock rats and identiffied genomic regions that inĚuence cocaine motivation and contain several
candidate genes. Increasing the power of this study in Aim 1 will enable the discovery of additional gene variants
contributing to the complex genetic landscape of SUD.
Yet, candidate genes must be investigated with follow-up studies. In a separate project, multi-level ‘omics’ data
(including GWAS results, phenome-wide association studies, and transcriptomics) were integrated to identify
candidate gene variants underlying cue-reactivity, a trait that that is phenotypically and genetically correlated
with measures of cocaine-cue reactivity. These candidates included the understudied genes Tenm4 and Far1.
Subsequent behavioral neuroscience-based approaches established that administration of a Tenm4-associated
peptide reduced several measures of cocaine motivation during IntA and thus conffirmed Tenm4's pleiotropic
eěect on cocaine motivation and cue-reactivity. However, further characterization of Tenm4 and Far1 is needed,
thus another goal of this project is to use CRISPR-based transcriptional manipulation to determine the roles of
these genes in cocaine cue-reactivity and motivation (Aim 2). Finally, another approach for validating GWAS
ffindings involves generating polygenic scores (PGSs) that can be used to predict cue-reactivity in naïve rats. In
Aim 3, these PGSs will be used to determine the interaction between genetic vulnerability to cue-reactivity and
changes in drug motivation during multiple cocaine self-administration paradigms.
Thus, this project will enhance the understanding of genetic factors inĚuencing SUD susceptibility, validate
candidate genes, and determine how genetic predisposition interacts with drug exposure to produce addiction-
like behaviors. These goals align directly with those of those of the NIDA Animal Genomics Program, that is,
“to identify [genetic variants] that underlie … phenotypes associated with addictive behaviors … behaviors
associated with SUD, [and] uncover the function of known or newly discovered genetic or epigenetic variants”.

Public health relevance
PROJECT NARRATIVE Understanding the genetic factors behind transitioning from recreational to problematic drug use is crucial for preventing and treating substance use disorder (SUD). This project will identify genes related to cocaine motivation and integrate data from other genomics projects to uncover and validate understudied genetic variants associated with SUD. Ultimately, our project aims to improve our understanding of SUD susceptibility, validate genes, and refine personalized treatment methods, thus aligning with the goals of the NIDA Animal Genomics Program.